Massively Parallel Biochemical Annotation of Missense DNA Variants to Support Newborn Screening by Whole Genome Sequencing

Project Summary
Newborn screening (NBS) provides early diagnosis of treatable disorders. Most NBS is based on
measurement of biomarkers in dried blood spots (DBS). However, there are hundreds of pediatric and
actionable diseases for which a biomarker is difficult to imagine. This has led to consideration of whole
genome sequencing as a new paradigm in NBS (newborn sequencing, NBSeq). NBSeq has significant
challenges one of which is the false negative problem expected when DNA variants of unknown significance
(VOUS) are ignored. Ignoring VOUS is a necessary element of NBSeq because downstream biochemical
analysis of all newborns with VOUS is not feasible because of the commonality of these DNA variants.
The goal of this grant is to develop and explore new technology for massively parallel, rapid, and
inexpensive biochemical annotation of VOUS. We have developed a new technique we call VOUSDO where
we prepare a library of DNAs that encode every possible amino acid substitution in a protein at one change per
protein. Human cells are then transfected with this library, and the cells are engineered to express only a
single protein variant per cell. The cells are also engineered to express an RNA barcode whose sequence
serves to identify the protein variant. After protein variant expression, the protein is engineered to capture its
respective barcode. The degree of barcode capture depends on the abundance of the protein. Thus, any
amino acid substitution that causes the protein to misfold and become degraded will lead to a protein variant
that under-captures its barcodes. Barcodes are converted to DNA at the end of the analysis and these are
subjected to next generation sequencing to reveal their sequences. The DNA sequence read frequency of
each protein variant is compared to that of the wild type protein to provide the fraction of variant that folds in
cells relative to wild type.
The above technique works for cytosolic proteins. For proteins that target cellular organelles or are
secreted, we will employ a second technique called VAMP-seq. Here, the protein is fused to a fluorescent
protein, and the degree of fluorescence depends on the level of folded protein expressed in cells. Again, cells
are engineered so that each cell expresses a single protein variant. RNA barcodes are used as well to identify
the protein variant. Fluorescence-activated cell sorting is used to collect cells depending on the extent of
fluorescence. Barcodes in each collection bin are read as for VOUSDO to give the relative extent of folding of
each variant relative to that of wild type protein.
These techniques have the potential to provide biochemical annotation of every single site amino acid
substitution in the full list of proteins being included in NBSeq pilot studies worldwide. Knowing which VOUS
greatly reduce the extent of protein folding is expected to massively reduce the false negative problem
associated with ignoring VOUS in NBSeq programs.

Public health relevance
PROJECT NARRATIVE There is growing interest in whole genome sequencing of newborn genomes as a way to expand NBS to include hundreds of pediatric and actionable diseases (newborn sequencing, NBSeq). In order to reduce false negatives due to variants of unknown significance (VOUS), we will develop two massively parallel, rapid, and inexpensive methods to biochemical annotate the degree of misfolding and degradation of all versions of a protein in which each amino acid is substituted by all possible 19 other amino acids at one substitution per protein.